E-FABP mediates n-3 fatty acid-induced tumor prevention through epigenetic control of immune cell differentiation and function

PROJECT SUMMARY/ABSTRACT
Despite therapeutic advances, over 600,000 people in the US will die from cancer in 2019. Preventing cancer
eliminates the risk of mortality and/or morbidity that may occur with the development of cancer. Thus, cancer
prevention represents the most effective way for addressing cancer challenges. Healthy diet is considered be
essential to reduce cancer risk by maintaining and improving immunity, but recent VITAL trials did not show
beneficial effects of these supplements. The negative results reflect the mechanistic knowledge gap of how
dietary factors modulate health. The objectives of this renewal application are to determine cellular and
molecular mechanisms by which epithelial fatty acid binding protein (E-FABP) promotes n-3 fatty acid-
mediated tumor prevention by enhancing immune cell differentiation and anti-tumor activity. Data collected in
the last funding cycle have successfully established E-FABP as a new host-derived cancer prevention factor in
non-obese subjects. During our studies, we observed that different types of high fat diets (HFD, 45% fat),
including cocoa butter (rich in saturated fatty acids, FAs), safflower oil (rich in 18:2 linoleic acid), fish oil (rich in
n-3 FAs), all induced similar degree of obesity in mouse models. However, tumor growth in these obese mice
was dramatically different with the fastest growth in cocoa butter group and slowest in the fish oil group. In
analyzing the immunophenotype of these obese mice, we found an atypical population of CD8+ γδ T cells that
was specifically upregulated in the fish oil group. More interestingly, fish oil diet-induced CD8+ γδ T
differentiation and anti-tumor effects were blunted in mice lacking E-FABP, suggesting a novel molecular
mechanism mediated by E-FABP. Thus, we hypothesized that host expression of E-FABP plays a critical role
in n-3 FA-induced immune cell differentiation and anti-tumor function. Three specific aims are proposed to
address the central hypothesis in this renewal application. Specific Aim 1 will determine the mechanisms by
which E-FABP promotes n-3 FA-induced immune cell differentiation. Experiments are designed to elucidate
molecular mechanisms by which consumption of dietary n-3 FAs regulate CD8+ γδ T cell differentiation via E-
FABP-dependent epigenetic reprogramming. Specific Aim 2 will delineate how E-FABP mediates n-3 FA-
induced anti-tumor activity. Results of Aim 2 are expected to reveal that E-FABP promotes host anti-tumor
activity through targeting both immune cells and tumor-derived epithelial cells. Specific Aim 3 will evaluate
whether targeting E-FABP with optimized n-3 FA diets results in effective tumor prevention. In summary,
successful completion of this proposal will offer E-FABP as a new cancer prevention target and have
significant mechanistic and clinical implications for healthy diet-mediated cancer prevention.

Public health relevance
PROJECT NARRATIVE Data from this study are expected to establish E-FABP as a novel molecular sensor mediating n-3 FA-induced anti-tumor effects. This proposal will not only have basic science ramifications for understanding molecular mechanisms by which n-3 FAs epigenetically enhance immune cell differentiation, but will also have significant translational implications for the role of healthy diets in cancer prevention.